Threshold, Severity, and Immunotherapy of Peanut Allergy

SUMMARY
Peanut allergy has tripled in prevalence in recent decades, affecting up to 5% of children in some US regions.
Peanut allergy is typically life-long, can be fatal, and impacts quality of life. These factors support our rationale
to continue studying peanut allergy for this renewal of our AADCRC. Our application addresses several unmet
needs in peanut allergy research and care. The unpredictable severity of peanut allergic reactions is a burden
for affected individuals. Current assays have limited utility in predicting reaction severity. Expanding our
mechanistic understanding of reaction severity is an essential step for guiding better treatment for peanut
allergy. Although oral immunotherapy (OIT) is gaining clinical use for desensitization, only one product
designed for low-threshold children is approved, and response to treatment is highly variable. Preliminary
results from a randomized clinical trial within our current AADCRC (2018-2023) support that there is a common
phenotype of high-threshold peanut allergy that is easy to treat. All who have completed high-dose peanut
butter OIT in our trial have demonstrated sustained unresponsiveness following OIT without any adverse
effects. Similar to the revolutionizing impact that prior Mount Sinai AADCRC studies of baked egg and baked
milk had on the treatment and understanding of egg and milk allergy, our current AADCRC’s findings could
alter the approach to peanut allergy worldwide for the ~50% who have high threshold peanut allergy. These
findings also emphasize that further research is needed to understand mechanisms underlying OIT and OIT
response across the threshold spectrum. The contrasting outcomes motivate examination of individuals of all
thresholds undergoing OIT to identify endotypes that can be used to personalize treatment. The next stage of
the Mount Sinai AADCRC will be a dual core, dual project program that focuses on new questions about
reaction severity, threshold, and immunotherapy of peanut allergy. We will address our overall hypothesis that
dynamic changes in circulating cellular subpopulations, molecular networks, and metabolic pathways are
mechanistically linked to peanut reaction severity and response to OIT. We will synergize Mount Sinai’s cutting
edge clinical OIT program via a clinical core (PATHWAYS) and administrative core with two complementary
research projects (ROSETTA and IMPALA) that will extend understandings of reaction severity, threshold, and
immunotherapy of peanut allergy. We will build on our innovation of assaying time series of blood samples
from children undergoing double-blind, placebo-controlled food challenges to study subjects of all thresholds
before and after OIT to identify in vivo mechanisms of reaction severity. ROSETTA will leverage integrative
transcriptomics and systems biology to uncover mechanisms underlying reaction severity, OIT, and endotypes
of OIT response. IMPALA will complement this effort with cell- and pathway-specific studies to expand our
understanding of innate immunity in anaphylaxis. Our integrated program will enrich mechanistic
understandings, advance personalized medicine, and identify new therapeutic targets for peanut allergy.

Public health relevance
PROJECT NARRATIVE Individuals with peanut allergy react to different amounts of peanut with varying severity and also have variable response to therapy. We will perform an integrated clinical and translational study of rigorously phenotyped peanut allergic children undergoing food challenges and immunotherapy to examine the cellular dynamics, molecular networks, endotypes, and innate immune mechanisms of reaction severity, threshold, and therapeutic response. Our project will advance mechanistic understandings and inform therapeutic approaches to peanut allergy and food allergy.